Cholinergic regulation of amygdalar circuits in emotional memory

Abstract
Anxiety and fear related disorders comprise some of most common mental illnesses. For anxiety disorders
alone, approximately 1 in 3 U.S adults will be affected at some point in their life. Currently available treatments
leave approximately 40% of patients without symptom resolution underscoring the need for new therapies to
be developed. A key to the rational development of new treatments is improved understanding of the
neurobiological mechanisms that regulate the neurons and circuits involved in fear and anxiety behaviors.
Areas of the brain involved in emotion, such as the basolateral amygdala (BLa) and medial prefrontal cortex
(mPFC) rely on synchronized neuronal oscillations in the theta band (4-12 Hz) to entrain local pyramidal
neurons (PNs) and synchronize activity across brain regions for proper long-range communication, and
information processing. Aberrant synchronization in these circuits contributes to deficits in emotion that
underlie fear disorders. However, despite the established role for theta oscillations in mPFC and BLa during
fear states, the mechanisms through which oscillations are generated in the BLa and synchronize with mPFC
are poorly understood. Critical to the function of these regions is the neurotransmitter acetylcholine (ACh),
which promotes emotional learning and theta oscillations in BLa and mPFC. Supporting the vital role of ACh in
emotional circuits is the finding that perturbations of cholinergic signaling produce a range of behavioral
effects, including anxiogenic, or anxiolytic states, depressive symptoms, and disrupted fear and extinction
learning. Moreover, in all mammals, including humans, the BLa receives by far the most robust cholinergic
innervation of any target of the cholinergic basal forebrain. Despite its remarkably dense cholinergic
innervation, and critical importance in emotional memory, surprisingly little is known about the mechanisms
through which ACh modulates BLa circuits. Therefore, the objective of these studies is to determine at a
cellular and circuit level how endogenously released ACh modulates amygdalar microcircuits to regulate fear
behaviors. Our central hypothesis is that ACh acts on distinct inhibitory microcircuits in the BLa to promote
local oscillations and synchrony between BLa and mPFC and enhance emotional memory. Our hypothesis is
based on preliminary data showing that basal forebrain-derived ACh alters BLa circuitry and facilitates
oscillatory synchrony with mPFC by differentially modulating distinct types of inhibitory interneurons in BLa.
Here, we propose to use electrophysiology, intracranial EEG recording, cell type specific targeting,
optogenetics, and behavior to determine the circuit mechanism by which synaptic acetylcholine modulates
local BLa oscillations (Aim 1), facilitates BLa-mPFC oscillatory synchrony and gates fear learning (Aim 2) and
regulates discrimination between safe and threatening cues (Aim 3). These studies will shed new light on
mechanisms underlying anxiety and fear disorders and the role of ACh in emotional processing.

Public health relevance
Narrative Cholinergic transmission in the amygdala is critical for emotional memory as demonstrated by the observation that deficits in this signaling underlie emotional disturbances associated with a variety of disorders, including Alzheimer’s disease, drug addiction, anxiety and trauma-related disorders, and schizophrenia. The goal of this project is to determine at a cellular and circuit level how cholinergic signaling modulates amygdalar circuits to regulate emotional memory. These studies will further our understanding of the cellular and circuit mechanisms by which acetylcholine acts to regulate emotion and inform novel avenues for the development of therapeutics to treat a variety of debilitating emotional disorders.